UCI P30 Skin Center Multi-Omics Core

Project summary/abstract
Technological advancements in omics technologies have revolutionized skin biology and disease research,
providing insights into wound healing, tissue regeneration, and disease mechanisms. The Genomics and
Bioinformatics Core of the Center has been at the forefront of these advances, employing cutting-edge omics
approaches, standardizing tissue dissociation protocols and data analysis, and contributing to advanced
bioinformatics analysis and data sharing. Their efforts have resulted in 30 publications over the past four years.
For the coming cycle, the Core has been renamed the Multiomics Core, reflecting its expanding capabilities to
include single-cell molecular studies, spatial omics analysis in tissues, and new ways to integrate
transcriptomics, ATAC-seq, and metabolomics data. The Core is led by Suzanne Sandmeyer, PhD., and Maksim
Plikus, Ph.D., who combine expertise in genomics and skin biology. The Core will develop a pipeline for
integrated data analysis and storage, enhance the SkinGenes.net portal with new visualization tools for
multiomics and spatial data, and provide workshops, training sessions, and consultation to support researchers
in skin-centric experimental protocols and data analysis strategies. The goal is to foster collaborations between
omics technology experts, bioinformaticians, skin biologists, and clinicians from UCI and beyond based the
development of accessible tools, analytics programs, and data sharing portals that advance skin research
globally.